FGF SIGNALING IN OCULAR NEOVASCULARIZATION

? DESCRIPTION (provided by applicant): Pathologic angiogenesis can cause blindness in numerous diseases of the eye including age-related macular degeneration (AMD) and diabetic retinopathy, and promote disease progression in several cancers. Although vascular endothelial cell- derived growth factor (VEGF) is critical to this process, therapies targeting VEGF have been unable to prevent abnormal blood vessel development and may be ineffective in a subset of patients, implicating other factors in the pathophysiology of disease. As such, it is critical t identify novel factors that may play a role early in disease and that are potentially independent of VEGF. We have recently identified the fibroblast growth factor (FGF) receptor signaling pathway as one that promotes choroidal neovascularization (CNV) in AMD. The mechanisms by which this occurs are novel and VEGF-independent. In these studies, we propose to identify the FGF ligands that drive pathogenic ocular neovascularization. Molecules identified by these studies are therapeutically accessible, potentially modifiable and might facilitate the development of targeted therapies to prevent blindness from complications of ocular neovascularization.

Public health relevance
PUBLIC HEALTH RELEVANCE: Pathologic angiogenesis can cause blindness in diverse diseases of the eye including age-related macular degeneration and diabetic retinopathy. Although vascular endothelial cell-derived growth factor is important in ocular neovascularization, therapeutic strategies aimed at blocking this factor have been unsuccessful at preventing neovascularization. As such, it is critical to identify novel molecular pathways that promote angiogenesis in eye disease. The current proposal will focus on the role of fibroblast growth factors that promote proliferative neovascularization in the eye.